Renovation for Neurophysiology Core B

PROJECT SUMMARY/ABSTRACT: ALTERATION AND RENOVATION
The proposed Balance and Auditory Research Center (BARC) at the University of Mississippi Medical
Center (UMMC) is designed to build a critical mass of independent investigators to develop effective diagnostic
and therapeutics for balance and auditory disorders. Building on existing programs, BARC’s overall goal is to
employ and expand innovative molecular, cellular, and physiological approaches to the study of balance and
hearing to develop novel diagnostic and therapeutic breakthroughs and provide advanced training and
mentorship opportunities for students, residents, and junior faculty.
One of BARC’s research cores, the Neurophysiology Research Core, often referred to as “Core C,” will
require alterations and renovations. The scope of work includes the addition of walls inside of R618 to create
two rooms (with the third area of focus residing in R618-01) and a walkway around them. Because of the type of
work that will be conducted, temperatures and sunlight will need to be controlled. The newly renovated space
will significantly increase Core C capacity to provide the auditory/vestibular functional test services to
investigators inside and outside of the BARC. Specific aims for the alteration and renovation of UMMC’s R618
for development of BARC’s Core C include the following: (1) finalize plans and receive necessary approvals from
UMMC to demolish certain facilities within UMMC’s R618 and construct new facilities in the same space to safely
and effectively accommodate Core C its initiatives; (2) complete alterations and renovations of UMMC’s R618,
including renovations of its ceiling and relevant interior elevations, within one year of funding; and (3) coordinate
efforts with the directors of both Core C and the Administrative Core to assure that all alterations and renovations
are satisfactory and accommodate the needs of CORE C initiatives.
Heading up the proposed alterations and renovations is Amy Trim, PLLC, who has a long history with UMMC,
renovating space on UMMC’s campus for similar projects. Ms. Trim earned her Bachelor’s degree in Architecture
and Master of Design degree from Auburn University, and interned with Miner Feinstein Architects, LLC in
Frederick, Maryland. She holds an active license (#5565) with the Mississippi Board of Architecture, and has
focused her work on hospitals and health care facilities since 2016.